Characterization of CLIC2

Project Summary
The proposal is focused on the physiological characterization of Chloride intracellular channel 2 [CLIC2, a
channel listed in FOA: RFA-RM-21-012 (Pilot Projects Investigating Understudied Ion Channels)]. CLIC2 was
identified as XAP121 in an attempt to characterize the 1200-kb telomeric region of Xq28. The region was
associated with hypertrophic cardiomyopathy and X-linked intellectual disability (XLID). Patients with mutations
in CLIC2 showed early onset of symptoms with death in infancy of some of the affected males and others at later
age points due to cardiomegaly. Though CLIC2 has been directly associated with X-linked pathological
conditions and episodic ataxia since 1997, information on its physiological roles and biophysical properties is not
yet established. In our preliminary experiments, we discovered that CLIC2 is essential for cardiomyocyte
differentiation. In its absence human induced pluripotent stem cell (hiPSC)-derived cardiomyocytes (CMs)
differentiate at a slower rate and differentiated cardiomyocytes have abnormal function. We have discovered an
unusual truncation mutation in CLIC2 in XLID patients who have reported dilated cardiomyopathy. In these
patients, a mutation in the clic2 gene leads to premature truncation of CLIC2 at leucine 92 (CLIC2 Δ92).
Therefore, we hypothesize that the novel mutation resulting in the truncation of C-terminus CLIC2
decreases the affinity of CLIC2 for RyR2 which worsens cardiac function in HCM patients by increasing
SR Ca2+ leak through RyR2 and abnormal cardiomyocyte differentiation. We also discovered a unique
peptide from CLIC2 that can rescue the function of cardiomyocytes lacking CLIC2. We have the following specific
aim, 1) to establish the role of CLIC2 Δ92 in the differentiation and function of early human cardiomyocytes, and
2) to establish the role of CLIC2 in the regulation of cytosolic calcium homeostasis. In Aim 1 we use a combination
of genetic and imaging approaches to elucidate the impact of CLIC2 mutations on cardiomyocyte differentiation
and function. In Aim 2 we will rescue the function of hiPSC-CMs lacking CLIC2 by a unique peptide and also
screen the FDA-approved small molecule library available at OSU. The proposal will enhance our understanding
of CLIC2 protein by establishing its mechanism in cardiomegaly. CLIC2 mutations are also associated with
autism, XLID, episodic ataxia, and learning disorders and the information obtained in our proposal could also
increase our understanding of CLIC2 in other pathological conditions.

Public health relevance
RELEVANCE. Mutations in CLIC2 are associated with X-linked pathological conditions and episodic ataxia but not much information is available on its functional role or mechanisms associated with these mutations. Here, using genetic and pharmacological approaches we will establish the physiological role of CLIC2 in cardiomyocytes as heart failure is the key cause of death in these patients. The results of this proposal will allow the advancement of CLIC2 as a regulatory ion channel and will present it as a potential interventional and therapeutic target for X-linked cardiomyopathies.